DIHYDROTESTOSTERONE HEPTANOATE TREATMENT OF GYNECOMASTIA

Increased production of estrogen from androgen is a significant cause of gynecomastia. Dihydrotestosterone therapy provides androgen therapy which cannot be converted to estrogen.